Virginia's FDA FERN Cooperative Agreement Proposal

Commonwealth of Virginia Division of Consolidated Laboratory Services FDA FERN Microbiological Cooperative Agreement Program PAR-09-215 Project Abstract The Division of Consolidated Laboratory Services (DCLS) serves the Commonwealth of Virginia as the State Laboratory providing analytical testing in support of foodborne disease surveillance outbreak response and large-scale food emergency testing in coordination with State analytical requirements. DCLS continues to use both state funds and FERN FDA Microbiological Cooperative Agreement (U18 FD003814) funding to strengthen and improve our capability and capacity to rapidly and accurately identify microbiological contaminants in food. Over the past three years, FDA FERN funding has enabled DCLS to participate in all offered surveillance assignments, proficiency testing, method evaluation studies and to learn and exercise the use of standardized analytical worksheets and electronic result reporting in collaboration with FERN . Continued support for personnel, equipment and reagents is necessary for DCLS to continue our full participation and support of these initiatives and to continue to strengthen our food testing program. This proposal identifies core yet critical resources necessary for DCLS maintain and strengthen our current capability and capacity to rapidly and accurately respond to issues of food safety and food security. Scientific personnel supported through FDA FERN Cooperative Agreement funding have invested hundreds of hours in training, competency assessments and establishing proficiencies in FDA standardized methods and instrumentation. Additionally, instrumentation has been maintained and supplies stocked in order to assure a ready state of preparedness. With 2012-2013 funding, DCLS proposes to continue to support the salaries of three FERN FDA scientists dedicated to FERN laboratory testing initiatives and to support emergency outbreak and surge testing needs. DCLS agrees to actively participate in all offered surveillance assignments, proficiency testing exercises and special projects as offered by the FERN NPO. DCLS will continue to collaborate with FDA subject matter expert to evaluate novel analytical methodologies to support and expand existing FERN methods in order to improve sensitivity and specificity of pathogen detection and recovery. In the event of a large-scale microbiological contamination event affecting foods, DCLS commits to assisting the other cooperative agreement laboratories with performing selected microbiological analyses of domestic and imported food samples collected and supplied by the FDA or other government agencies through FDA. DCLS will perform standardized methods and generate quality controlled and assured analytical data in compliance with regulatory requirements as requested by FDA NPO. DCLS will also engage in studies aimed at the method development, validation and matrix extension of methods as directed by the FERN NPO. Additionally, DCLS will provide all analytical data for potential regulatory action to FERN NPO as instructed using standardized analytical worksheets and reporting methods.

Public health relevance
Project Narrative FDA FERN Microbiology Cooperative Agreement Program funding will be used to provide continued support for existing personnel, maintain equipment and purchase testing supplies and reagents to increase Virginia's capability and capacity to respond to foodborne outbreaks and other large-scale food emergency events. Funding will allow the Virginia Division of Consolidated Laboratory Services, Virginia's State Laboratory, to provide analytical testing in support of state and federal food safety initiatives and continue to work collaboratively with the FDA to standardize test methods and result reporting. __SpecificAimsTextDelimiter__ Commonwealth of Virginia Division of Consolidated Laboratory Services FDA FERN Microbiological Cooperative Agreement Program PAR-09-215 Specific Aims 1) Continue to support the salary of three laboratorians (1 Senior Scientist and 2 Scientists) in order to assure the availability of dedicated personnel to participate in all required FDA FERN sample analysis activities including surveillance testing assignments, proficiency testing, check sample testing, food emergency outbreak testing, large scale food emergency surge capacity needs and new method enhancement studies. 2) Participate, as requested, by FDA FERN in all surveillance testing assignments, proficiency exercises, and routine and emergency surge testing situations to assure a rapid and timely response to potential food contamination events. DCLS will maintain open communications with FDA FERN NPO and assure that all information and laboratory results are available as requested. 3) Provide analytical data and worksheets as requested by FDA for regulatory use and will continue to work with FDA to use standardized reporting forms (ie. 431 forms), to use validated and/or standardized analytical testing methods, use approved equipment platforms (FDA and DCLS purchased) and follow instructions relating to verbal and written FDA result notifications including use of eLEXNET. 4) Work with existing DCLS staff to identify gaps as they relate to DCLS' ongoing efforts to establish ISO17025 accreditation. As part of these efforts, FDA FERN personnel will initiate efforts to harmonize DCLS procedures and processes with the recommendations in the Food Safety and Modernization Act as this information is provided to laboratories involved in food testing. 5) Work with DCLS StarLIMS information management team to interface eLEXNET in order to provide the most efficient and productive method for streamlining manual data entry method of results communication to FERN. Personnel will work with FDA to standardize and implement approved reporting methods until eLEXNET can be interfaced. Alternatively, manual data entry can be employed to allow for both paper and electronic documentation of testing results. 6) Participate as requested or offered by FDA, in small and/or large scale method development initiatives, validation studies and matrix extension work in collaboration with FERN. 7) Renew service contracts on all FDA-funded instrumentation and other critical instrumentation used in FDA FERN methods for the detection of agents in food. All service contracts will be renewed at least one month prior to expiration in order to assure functionality and a ready-state of preparedness. 8) Purchase all required supplies and reagents to successfully and completely conduct the above proposed testing. An inventory list of all purchased items will be electronically maintained in our procurement records and will be available for review upon request. 9) Send FERN and DCLS food scientists to FERN trainings, professional development courses, and FERN meetings. Funds will be used to support travel and registration fees associated with these events. 1